A Hypertension Emergency department intervention Aimed at Decreasing Disparities

? DESCRIPTION (provided by applicant): Effective interventions that can address uncontrolled hypertension, particularly in underrepresented populations that use the emergency department (ED) for primary care, are critically needed. Uncontrolled hypertension (HTN) contributes significantly to cardiovascular morbidity and mortality and is more frequently encountered among patients presenting to the ED as compared to the primary care setting. EDs serve as the point of entry into the health care system for many high-risk patient populations, including minority and low-income patients. Based upon recent studies, the prevalence of uncontrolled/undiagnosed HTN in patients presenting to the ED is alarmingly high. Thus emergency department engagement and early risk assessment/stratification is a feasible innovation to help close health disparity gaps in HTN. This application involves a three-arm randomized controlled trial of 600 patients from the Emergency Department at University of Illinois Hospital with elevated blood pressure (BP) and no established PCP. The overarching goal is to improve follow-up rates and transition to PCP care at a federally qualified community health center (FQHC). The primary outcome will be blood pressure improvement and control. The central hypothesis of our application is that an ED-based screening, brief intervention, and referral for treatment program for HTN (SBIRT-HTN) using existing ED resources, coupled with a follow-up visit to an ED pharmacist-initiated Post-Acute Care Hypertension Transition Clinic (PACHT-c), can improve BPs by increasing follow-up rates, and consequently, treatment compliance and BP control in a predominately underrepresented hypertensive population.

Public health relevance
PUBLIC HEALTH RELEVANCE: Hypertension affects more than 76 million individuals in the United States and uncontrolled hypertension is the primary risk factor for the subsequent development of cardiovascular complications such as heart failure, renal failure, and stroke. The overarching goal of this application is to improve blood pressure control by increasing hypertension knowledge through a brief educational intervention and facilitating primary care follow-up management. This application targets an underrepresented patient population with uncontrolled hypertension identified in the emergency department, which serve as the point of entry into the health care system for many high-risk patient populations, particularly minority and low-income individuals.